Development of a Standardized, Reliable and Easy-to-Use Clinical Instrument to Measure First Ray Mobility and Position of the Medial Forefoot to Assist with Clinical Decisions and Treatments

Project Summary
During the I-Corps program, the aim will focus on diverse customer discovery to gain a clearer understanding
of the customer segments and revenue streams, transformation of the team’s invention to impact, defining the
value proposition, advancing the technology from the research lab to the commercial world, and meeting
unmet clinical needs. Over 100 stakeholders will be surveyed. The result evaluation, together with knowledge
gained during the I-Corps curriculum, will be used to strengthen our commercialization plan. The parent SBIR
Phase I aim is detailed below.
Osteoarthritis (OA) research has focused on the hip, knee, and hand, with sparse attention to the foot. First
metatarsophalangeal (MTP) joint OA (Hallux Rigidus), a source of substantial pain and limited mobility, is the
most common degenerative disease in the foot. Excessive or insufficient 1st ray mobility (FRM) has been
associated with numerous painful, disabling, and limb threatening pathologies. First ray mobility is the superior
or inferior displacement of bony structures along the MTP joint in response to vertical load. While a couple of
laboratory devices exist to test 1st ray hypermobility (FRM ≥8mm), there are no commercially available,
reliable, user friendly, FRM devices for the clinic. The 1st Ray Mobility and Position (MAP1st) version 1 (V1)
prototype (PCT/US21/22791) has several limitations. The Specific Aim of the parent SBIR Phase I project
is to develop MAP1st version 2 (V2) to increase the reliability, utility, efficiency, and ease of use for
measuring FRM, position, and stiffness.
MAP1st V2, is being prototyped to address the limitations of MAP1st V1. A focus group study has revealed
some useful features to address customer needs. A data set (n=80 feet) will be acquired from 20 healthy
individuals with asymptomatic rectus and planus feet, and 20 individuals with pathology. Intra-rater and inter-
rater reliability will be assessed from replicated measures, while subgroup differences will also be examined.
Device utility will be assessed by distinguishing FRM between the healthy and pathologic groups using
Generalized Estimation Equations. A usability questionnaire will assess clinician ease of use for V1 versus V2.
Three hypotheses will be tested for the SBIR Phase I project: (1) Intra-rater and inter-rater reliability will exhibit
an ICC (2,1)>0.75 for use of MAP1st V2; (2) First ray mobility, position, and stiffness will be different across
individuals with asymptomatic rectus, asymptomatic planus, hallux valgus, and hallux rigidus feet,
demonstrating device utility; and (3) Usability and efficiency will be improved between MAP1st V1 and V2.
This investigational team has collaborated on 10+ projects and co-published 50+ publications on foot
biomechanics. Further, pilot data supports MAP1st ability to detect hypermobility in planus vs. rectus feet.
Hence, a successful completion of this project is anticipated.

Public health relevance
Project Narrative Hallux valgus and hallux rigidus both cause pain, reduced step length, diminished walking speed, and disability. First ray hypo and hypermobility are associated with these degenerative pedal pathologies but, currently, there are no commercially available devices that can measure mobility in a reliable manner. If funded, the proposed device could address this unmet clinical need, translating the innovation to market, and allowing clinicians to measure first ray mobility in a reliable, utility-centric, usable, and efficient manner while personalizing the patient’s treatment to enhance health by reducing disability.